The epigenome-metabolism nexus as a driver of circadian disruption in Alzheimer's disease

Altered circadian rhythms and sleep patterns are a hallmark of both aging and neurodegenerative diseases
including Alzheimer’s disease (AD). Disruptions in circadian behaviors are observed at an early stage of AD and
emerging evidence suggests that these might not simply be a symptom of disease, but could also contribute to
pathogenesis. Notably, these disruptions in circadian behaviors are also observed in both aging Drosophila and
in fly models of AD, indicating that Drosophila provides a genetically tractable model system in which to identify
the conserved mechanisms underlying AD-associated circadian disruption. Circadian rhythms are controlled by
a molecular clock that consists of a transcription-translation feedback loop that requires the rhythmic deposition
of chromatin marks for its proper regulation. The deposition of these chromatin marks is mediated by enzymes
that use key metabolic intermediates as substrate, providing a connection between the metabolic state of a cell
and its epigenome. During aging, we and others have observed changes in the metabolic pathways that produce
the donor molecule required for histone and DNA methylation, S-adenosylmethionine (SAM) – referred to as
one-carbon metabolism. In the aging Drosophila head, we observe changes in one-carbon metabolism including
an increase in levels of S-adenosylhomocysteine (SAH), which inhibits the activity of methyltransferases. Similar
changes in SAM and SAH levels have been reported in clinical samples from AD patients, suggesting that these
metabolic changes are a common feature of aging and neurodegenerative disease in both flies and humans. In
both flies and mice, the circadian clock is necessary to prevent age-dependent retinal degeneration and
neurodegeneration, suggesting that disruptions to circadian rhythms in AD could indeed contribute to
pathogenesis. Here, we propose to expand our lab’s current aging studies into the context of AD by testing if
AD, like aging, leads to changes in one-carbon metabolism that alter the methylation capacity of peripheral clock
cells leading to epigenetic changes that disrupt circadian rhythms. Based on our preliminary data, we will focus
on two enzymes that control the ratio of SAM to SAH in flies: Glycine N-methyltransferase (Gnmt) and
Adenosylhomocysteinase (Ahcy). We propose that the changes in the SAM:SAH ratio observed in aging and in
AD patients could be generated by increased expression of Gnmt, which is induced by inflammation, and/or by
decreased activity of Ahcy, which is inhibited under exposure to oxidative stress. Notably, Gnmt plays a similar
role in one-carbon metabolism to that of an enzyme that is also upregulated in the brains of AD patients:
nicotinamide N-methyltransferase (NNMT). We will determine how AD-associated tau alters circadian gene
expression, one-carbon metabolism, and histone methylation, and use genetic approaches to test if Gnmt,
human NNMT, and Ahcy are necessary and/or sufficient to explain the impact of tau on circadian behavior.
These studies will provide the basis for expanding our work on metabolism, epigenetics, and circadian behavior
from the aging eye into the context of neurodegenerative disease with a particular focus on AD.

Public health relevance
Disruptions in circadian behavior and sleep patterns are a symptom of Alzheimer’s disease and related dementias, and these disruptions are also observed in Drosophila models of Alzheimer’s disease. Here, we will investigate how Alzheimer’s disease impacts metabolism and gene expression in the clock cells within the brain and eye that control rhythmic gene expression and behavior. We propose that Alzheimer’s disease disrupts rhythmic gene expression by altering the activity of metabolic enzymes that control levels of the precursors used for deposition of epigenetic marks such as histone methylation.